Multi-Scale Engineering of Heterogeneity in the Host-Aware Synthetic Gene Circuits

1 Current approaches to designing and constructing synthetic gene circuits have reached a
2 dilemma due to the substantial heterogeneity driven by circuit-host interactions, especially for
3 large-scale gene circuits. The conventional trial-and-error iteration approach on synthetic gene
4 circuit development is regarded as inefficient since the assembled gene circuits often are
5 susceptible to experimental conditions. One fundamental reason is that the heterogeneity driven
6 by circuit-host interactions become significant with the increase of the number of components in
7 gene circuits but are often neglected. Moreover, the lack of quantitative frameworks for quantifying,
8 characterizing, and controlling heterogeneity in the host-aware synthetic gene circuits impedes
9 the progress in the field. My laboratory has been focusing on dissecting the mechanisms of how
10 the circuit-host mutual interactions affect the gene circuit functions and developing control
11 strategies targeting circuit-host interactions to optimize engineered synthetic gene circuits.
12 Recently we found a topology-dependent interference of synthetic gene circuit function by growth
13 feedback, which was published in Nature Chemical Biology. We also found winner-takes-all
14 resource competition that redirected cascading cell fate transitions, which is in revision to Nature
15 Communication. In the proposed projects, we will establish experimental and computational
16 frameworks to quantify, characterize, and control the gene expression heterogeneity in the host-
17 aware synthetic gene circuits. The heterogeneity can result from stochastic cellular resource
18 allocation, stochastic biochemical reactions in gene circuits, and stochastic cell divisions. These
19 heterogeneities are intertwined due to the complex interactions between the gene circuits and the
20 host organisms, creating another layer of challenge and complexity to engineering robust gene
21 circuits. We will integrate a microfluidics system for time-lapse live-cell analysis, a Turbidostat
22 platform with Python-based easy-to-use web interface for accurate growth rate control and
23 automatic yet remotely-controllable in-situ fluorescence measurement, and hybrid agent-based
24 modeling algorithms for stochastic simulation of all the single cells in the bacterial community to
25 characterize the heterogeneity from various noise sources in the host-aware synthetic gene
26 circuits. I have built up my research group with all the necessary expertise and capabilities to
27 complete the proposed projects. This work will provide a systematic in-depth mechanical
28 understanding of the heterogeneity driven by circuit-host interactions, and will greatly help us to
29 rationally design and control the synthetic gene circuits for sophisticated clinical applications in a
30 real-world environment, such as bacterial infection and tumor microenvironments.

Public health relevance
Project Narrative Sophisticated synthetic gene circuits have been designed and constructed for clinical applications, such as treating infectious diseases and cancer. However, the substantial heterogeneity resulting from the interactions between the gene circuit and host cells significantly affects the functional robustness of engineered gene circuits. Our proposed studies aim to quantify, characterize, and control heterogeneity in the host-aware synthetic gene circuits and make the circuits operate as desired in a complicated real-world environment.